Administrative Core

PROJECT SUMMARY: Administrative Core
The goals of the Administrative Core are to provide oversight and cohesive organization, so that the Aims across the Center can be achieved with maximal efficiency and impact. The Administrative Core is led by Center Director, Dr. Mark Thomas, Professor in the Department of Neuroscience. Dr. Thomas has been the Director of the Center as well as the Administrative Core Lead during the current funding cycle. Dr. Thomas is also a long-standing NIDA-funded investigator who has been researching the neural circuits underlying drug addiction since the late 1990’s. During his tenure at the University of Minnesota (UMN), he has launched two successful Core facilities and is also the Director of the UMN’s Medical Discovery Team on Addiction (MDTA). Our Administrative Core is organized to fulfill the following Specific Aims: Aim 1. Maintain our administrative framework with clearly defined roles and responsibilities. We designed our Center with several groups of investigators and advisors, each with well-defined roles and responsibilities, to carry out the mission of the Center. In addition to the Center Director and the Core co-Leads, these groups include the Steering Committee, responsible for governance of Center operations, and the Scientific Advisory Panel, composed of internal and external advisors, responsible for technology consultation and development. Working together, these entities ensure the Center has the maximal impact on science. Aim 2. Maintain and expand the Center’s initiatives to promote education, training, science and technology dissemination and outreach opportunities. We propose a variety of measures that will promote: a) effective use of the scientific resources in the Center by individual Investigators, regardless of their level of prior experience with the technologies; b) widespread dissemination of the science made possible by the Center; c) sharing of the technology and, when feasible, data sets, for use by the international scientific community; d) execution of our Data Management Plan; and e) extensive opportunities for trainees in addiction neuroscience to learn and utilize ground breaking technologies in their research and training